Synapse-specific plasticity in thalamoaccumbal output circuitry disinhibits relapse to opioid seeking

Suppression of reward-seeking behaviors is critical for survival, yet chronic opioid use and relapse
commonly occur despite known social, economic, and health consequences among Veterans suffering from
opioid use disorder (OUD). Thus, defining how opioid use influences the neuronal systems responsible for
suppressing reward-motivated behaviors is critical for understanding the etiology of OUD. Despite this
knowledge, no studies to date have tracked activity in single neurons from initial opioid use to dependence,
limiting our understanding of how brain circuits responsible for suppressing maladaptive behavioral actions are
modulated to unleash excessive opioid seeking and consumption. My lab has overcome this issue by developing
a novel mouse behavioral assay that allows longitudinal tracking of activity in precisely defined neuronal circuit
elements across heroin self-administration, extinction, and reinstatement. Using this paradigm, I will test the
hypothesis that a thalamoaccumbal to parvalbumin interneuron circuit is weakened by opioid use to causally
disinhibit opioid self-administration and relapse to opioid seeking.
Recent work in my laboratory, as well as the work of others, reveals that neurons in the posterior
paraventricular nucleus of the thalamus (pPVT) provide a critical ‘brake’ that suppresses inappropriate reward-
motivated behaviors through the activation of downstream nucleus accumbens (NAc) parvalbumin interneurons
(PV-INs). Despite the demonstrated role of this pPVT→NAcPV-IN circuit for suppression of reward seeking; the
activity, physiology, and function of this circuit for controlling opioid-seeking behaviors remains unclear. Based
on extensive preliminary findings, here I will test the overarching hypothesis that heroin self-administration
reduces pPVT→NAcPV-IN circuit activity and connectivity, causally disinhibiting heroin use and relapse to heroin
seeking. I will test independent components of this hypothesis through the completion of 3 independent Aims. In
Aim 1, I will use two-photon calcium imaging to measure the activity dynamics of pPVT→NAc axons and
downstream NAc PV-INs across heroin self-administration, extinction, and reinstatement. In Aim 2, I will use
slice patch-clamp electrophysiology to characterize synaptic adaptations within pPVT→NAcPV-IN circuits caused
by heroin self-administration. Finally, in Aim 3 I will use optogenetic and chemogenetic strategies to determine
the necessity and sufficiency of pPVT→NAcPV-IN circuit dynamics for heroin self-administration and relapse to
heroin seeking. Overall, I investigate how a principle, but understudied, behavioral suppression circuit is modified
by opioid use to unleash maladaptive opioid-seeking behaviors. Our preliminary findings suggest that this project
will be highly impactful for the field and could inform circuit-based therapeutics that normalize neuronal activity
for treatment of Veterans suffering from OUD.

Public health relevance
Reward seeking is normally suppressed in inappropriate conditions, yet opioid use and seeking often occur despite negative consequences in Veterans who are disproportionally vulnerable to opioid use disorder (OUD). We recently found that activity in a novel brain circuit, from paraventricular thalamus to accumbal parvalbumin interneurons, provides top-down inhibitory control over natural reward-motivated behaviors. Here we determine the influence of opioid self-administration on activity and plasticity in this thalamo-accumbal ‘brake’ for reward seeking, and further determine the function of this pathway for opioid seeking and use. Based on preliminary findings, we predict that selectively rescuing activity within cell-type specific thalamo-accumbal output circuits will prevent relapse to opioid use. Such findings would not only provide key mechanistic insight into the neurobiology of OUD, but would also provide candidate neuronal substrates that could be targeted for therapeutic intervention.